Validation of the Remote Cognitive Aging and Alzheimer’s Disease REsearch (R-CARE) Toolbox for Diverse Populations

ABSTRACT
In-person administration is the current “gold-standard” for assessment of cognition and function
in studies of Alzheimer’s disease and other dementia (ADRD). Remote neuropsychological
assessment has been advocated to overcome various access barriers and decrease costs of
neuropsychological services. Moreover, due to the pressing challenges and safety concerns
imposed by the COVID-19 pandemic, there is an urgent need for robust methods for assessing
and monitoring cognitive and functional status through remote assessments. The overall goal of
the current project is to validate, refine, and calibrate the Remote Cognitive Aging and Alzheimer’s
Disease REsearch (R-CARE) Toolbox for the assessment and monitoring of cognition and
function in a diverse sample of initially dementia-free older adults. The toolbox will include
measures from the Uniform Data Set, Neuropsychological Battery (UDSNB-3.0), complemented
by frequently used tests in preclinical AD trials. In-person tests that pose challenges for remote
administration will be replaced with tablet-based computerized tasks. We will recruit 600
dementia-free, racially/ethnically diverse (~ 1/3 non-Hispanic Black, 1/3 Hispanic, and 1/3 non-
Hispanic White), community-residing participants aged ≥65 years. A randomized,
counterbalanced design will be used to administer a comprehensive clinical and cognitive battery
across both assessment modes (in-person vs. remote) separated by 2-6 weeks at baseline, with
follow up visits at 18 and 36 months. Digital biomarkers (computerized tests and speech-based)
and ADRD blood-based biomarkers will be collected. AIM 1: To evaluate the psychometric
properties of remote cognitive tests and assess their validity against standard in-person tests.
AIM 2: To evaluate comparability of longitudinal change in global cognition and within cognitive
domains across modes of assessment (in-person vs remote) for the whole sample as well as
subgroups defined by sex and race/ethnicity. AIM 3 (exploratory): To identify novel digital
biomarkers that provide incremental validity for differentiating clinical and pathological disease
stages, and for measuring and predicting cognitive and functional decline. Collectively, this study
will validate remotely administered tests across different cognitive domains, provide evidence for
cross-sectional and longitudinal validity, and provide normative data for remote tests in diverse
populations. Our long-term goal is to develop an open-source, reliable and valid toolbox that
would enable AD-researchers and clinicians to evaluate older adults from diverse backgrounds
regardless of ability to attend in-person visits.
1

Public health relevance
We aim to validate a comprehensive remote neuropsychological toolbox, which would enable researchers and clinicians to accurately and reliably assess cognition and function of older adults who are at risk of Alzheimer’s disease and other dementia (ADRD) when in-person assessments are not feasible or safe. Remote assessment will facilitate more frequent evaluations at lower cost, potentially improving sensitivity, reliability, and validity of cognitive assessment for observational studies, clinical trials and clinical practice. The diverse older adult cohort afforded through the Bronx community will advance our understanding of disparities in ADRD, which will have implications for intervention and disease monitoring in future studies.